Acquired CFTR Dysfunction in Alcohol-related Lung Pathology

Alcohol abuse is a leading cause of disease and death in the United States. Alcohol consumption impairs lung
defense and increases the risk of bacterial pneumonia. Alcohol users with pneumonia respond poorly to
antibiotics, experience more severe symptoms and higher rates of mortality. Mucociliary clearance (MCC) is a
primary lung defense mechanism against inhaled/aspirated pathogens and is impaired by excessive alcohol
use. Unfortunately, our limited understanding of alcohol effects has prevented the development of interventions
to reverse mucociliary dysfunction and augment host immunity against infections.
Recently, we reported that alcohol reduces ion transport function of CFTR, the defective channel that
causes cystic fibrosis lung disease, which is also characterized by diminished MCC and frequent infections.
Supporting this discovery, patients with alcohol-induced pancreatitis (another disorder that is causally linked
with CFTR defects) were found to exhibit lower CFTR activity even after they abstained from drinking. Of note,
these patients had normal CFTR genetics excluding the role of inherited defects and thus, confirming the
phenomenon of ‘acquired CFTR dysfunction’.
Our preliminary studies in rat model of chronic alcohol administration detected substantially reduced
CFTR ion transport, increased mucus viscosity and, dramatically decreased MCC. When compared to their
pair-fed controls, alcohol-treated rats failed to clear Klebsiella pneumoniae and, exhibited histopathologic
evidence of severe pneumonia. Our data indicate alcohol increases the activity of phosphodiesterase-4B
(PDE4B) enzyme that specifically degrades cAMP causing reduced PKA-dependent phosphorylation and
opening of CFTR ion channels. Moreover, we demonstrate that roflumilast, a clinically used PDE4 inhibitor, is
successful in restoring cAMP levels in alcohol-treated cells and reversing CFTR dysfunction and mucus
abnormalities in alcohol-treated rats.
Guided by these strong preliminary data, we propose to pursue three Specific Aims to investigate how
alcohol-induced CFTR dysfunction may cause susceptibility to bacteria pneumonia: (1) Determine the specific
contribution of reduced CFTR function to alcohol-induced defects in mucociliary clearance. (2) Determine the
molecular mechanisms underlying alcohol-induced CFTR dysfunction. (3) Determine the clinical benefits of
reversing alcohol-induced CFTR dysfunction towards preventing bacterial pneumonia.
Collectively, our proposed research will broadly impact the field by characterizing the essential role of
CFTR dysfunction in compromising lung defense in alcohol users. These studies will have the potential to
uncover novel molecular mechanisms underlying bacterial pneumonia as well as advance new treatment
approaches to reduce disease burden. These findings may be extrapolated to other non-pulmonary alcohol
use disorders such as pancreatitis, diabetes and infertility, where there are similar therapeutic needs and
knowledge gaps regarding the pathogenic role of CFTR dysfunction.

Public health relevance
Pneumonia is a leading cause of death in the U.S. and an improved understanding of key risk factors is needed to reduce its burden. Alcohol is the most frequently abused substance that also increases susceptibility to bacterial pneumonia. We have identified that CFTR-mediated ion transport is decreased by alcohol, and may be responsible for reduced mucociliary clearance of inhaled pathogens. Hence, we propose to determine mechanistic basis and test novel treatment approach to restore CFTR function and lung defense against bacterial infection.